Researcher Responsibilities’ to Non-Participants in Community-based Pragmatic Clinical Trials

PROJECT SUMMARY/ABSTRACT
Studies of cardiovascular disease increasingly embrace pragmatic clinical trials (PCT) to evaluate interventions
under real-world conditions, often targeting under-resourced populations with high disease prevalence and
disproportionate exposure to environmental risk factors, to generate data that may be more translatable and
patient-centered than data from traditional randomized control trials. Community-based PCTs have several,
morally-salient characteristics that raise novel and pressing ethical questions relating to researchers’
responsibilities and human protections. These studies are (1) often intentionally conducted in populations with
high disease prevalence and limited available health care resources; (2) tend to impose upon, and extract
value from, communities and community-based organizations that are socio-economically vulnerable; (3) occur
outside the clinical setting, thereby positioning researchers in close physical proximity to participants or non-
participants who could benefit from the research team’s knowledge, network, or clinical judgement.
In turn, community-based PCTs prompt us to reconsider researcher responsibilities to not only protect from
research-related harm but also to provide assistance or benefit to members of the community in which the
study is conducted. There is a notable dearth of work attending to the ethics of PCTs conducted in community
settings, which the proposed bioethics administrative supplement addresses by leveraging the study design
and community relationships of the parent grant, AirPressureNYC (HL168597). The parent grant employs a
sham PCT design to evaluate the effect of indoor portable air cleaners on blood pressure of New York City
public housing residents with stable hypertension. Thus far ≥10% of individuals who directly interact with the
research team through the screening process have been excluded from the study, most often because of
asymptomatic hypertension above the inclusion criteria of 160/90 mmHg. The research teams’ ambivalence
about how to manage their relationship to these individuals is what first motivated this line of inquiry.
In the proposed supplement, we will empirically explore public and key stakeholder opinions on investigators’
obligations to members of communities engaged in PCTs, including study participants and non-participants,
with specific focus on individuals excluded after screening. We will then conduct a normative analysis using the
empirical data along with a thematic synthesis of the relevant literature to generate an ethical framework for
characterizing and meeting these researcher obligations, directly informing guidance for PCT protocol
development and oversight. This research will provide practicable directives for the ethical conduct of
community based PCTs, specifically addressing NHLBI research priorities of confronting bioethical issues
relevant to novel trial design and investigations involving vulnerable populations.

Public health relevance
PROJECT NARRATIVE: We will conduct a mixed-methods study, employing a national online survey and in-depth qualitative interviews, of public and key stakeholder perspectives on investigators’ responsibilities to research participants and non- participants in community-based pragmatic clinical trials (PCTs). We will then undertake a normative ethical analysis, informed by our empirical findings and a thematic synthesis of the relevant literature, to develop an ethical framework for community-based PCT protocol design. We will translate this framework into practicable directives for investigators and research oversight entities for the ethical conduct of community based-PCTs, specifically addressing NHLBI research priorities of confronting bioethical issues relevant to novel trial design and investigations involving vulnerable populations.